The contribution of gut microbiome composition to natural variation in sleep and aggression across populations in the blind Mexican cavefish

Project Summary
Sleep and aggression are two complex behaviors that have recently been found underlying the
emergence of neuropsychiatric disease. While large efforts have focused on genetic and environmental
factors underlying variation in sleep and aggression, a missing puzzle piece is whether the gut microbiota
contributes to these changes. Our goal is to understand the relationship between gastrointestinal (GI)
microbiota and natural variation of sleep and aggression. Understanding how differing GI microbiota
across phenotypically distinct populations of the same species impact sleep patterns and aggression
would provide a missing link between genetic and environmental variation in the production of complex
behaviors. To test this, we turn to the Mexican tetra, Astyanax mexicanus, a fish species comprised of
two morphotypes with variable behavioral phenotypes: river-dwelling surface fish and blind cave-dwelling
cavefish. Specifically, most populations of cavefish display reductions in sleep and aggression, while also
exhibit variation of GI microbiota even in lab-reared conditions. Our central hypothesis is that GI
microbiota influences the plasticity of sleep and aggression in surface fish and cavefish of the Mexican
tetra. We designed 2 aims to directly test this hypothesis. In aim 1, we will ask how different dietary
regimes impact microbial diversity associated to the gut in surface fish and cavefish, while correlating
these with sleep and aggression. In aim 2, we will ask whether swapping GI microbiota between surface
fish and cavefish through generating germ-free strains of each population will correlate with shifts in sleep
and aggression. We expect lower nutritional value diets to impact GI microbial diversity and reduce sleep
and aggression in surface fish but not cavefish, while sleep and aggression phenotypes will be reversed
between the 2 ecotypes following swapping of GI microbiota. Taken together, we expect a strong
correlation between GI microbial diversity and variation in sleep and aggression, potentially involving an
interplay with neural circuitry during development in populations of A. mexicanus. Combining my
expertise studying behavioral variation in A. mexicanus as a postdoc with my interest in uncovering the
different levels underlying these changes which potentially include variation of the gut microbiome males
me an ideal candidate to join and receive support from the new COBRE Center for Microbiomes Sciences
at the University of Puerto Rico.

Public health relevance
Project Narrative Communication between the gut microbiome and the central nervous system underscores a shared contribution to the ontogeny of behavioral disorders, like those associated to sleep and aggression. By manipulating diets and using antibiotics in a fish model with gut microbiome variations, we propose to uncover how microbial diversity in the gut helps shape changes in sleep and aggression.